Administrative Supplement for DePaul-Silva K22 award

Abstract/Project Summary
Temporal lobe epilepsy (TLE) is the most prevalent form of acquired epilepsy. 30% of the patients are
refractory to therapy and new treatments are urgently needed. Viral infection of the central nervous system (CNS)
is a significant cause of TLE, and, while encephalitis is an important contributor, the mechanisms of how
inflammation leads to seizures is unclear. Using the first mouse model of viral-induced TLE, which was developed
by our laboratory, we found that induction of acute seizures is associated with blood peripheral macrophage
infiltration into the brain and secretion of pro-inflammatory cytokines, primarily IL-6.
Through RNA sequencing (RNAseq) of infiltrating macrophages isolated from the brains of TMEV-infected
mice at the peak of seizure activity, I found that a population of CNS-infiltrating macrophages expresses high
levels of the triggering receptor expressed on myeloid cells-1 (TREM1). Activation of TREM1 leads to the
secretion of pro-inflammatory cytokines. Increased TREM1 expression is associated with inflammatory
conditions, and inhibition of TREM1 function ameliorates inflammation and disease severity in several animal
models of inflammatory diseases. However, the involvement of TREM1 in the development of acute seizures is
unknown. In Aim 1 I will determine the time course of TREM1 expression in brain-infiltrating macrophages, and
address whether genetic and pharmacological inhibition of TREM1 decreases the development of acute seizures
in TMEV-infected mice, via videoEEG. The pro-inflammatory cytokine IL-6, which is mainly produced by brain
infiltrating macrophages during TMEV infection, plays a pivotal role in inducing seizures; however how IL-6 does
it is unknown. In Aim 2, I will determine whether IL-6 induces downregulation of neuronal GABA receptors, via
biotinylation assay, and address which IL-6 pathway (classical or trans-signaling) is involved in acute seizures.
Since inflammatory macrophages in the brain are associated with generation of acute seizures in TMEV-infected
mice, in Aim 3 I will determine whether skewing macrophages towards an anti-inflammatory phenotype will affect
the development of acute seizures, via videoEEG. I will also identify microRNAs in brain-infiltrating macrophages
that are driving inflammation during the course of acute seizure generation in TMEV-infected mice. VideoEEG
and receptor biotinylation assay are critical techniques I will learn during my mentored phase (Aim1/Aim2a), that
will be essential to carry out experiments in Phase II (Aim2b/Aim3). These new skills, combined to my previous
training, will put me in a unique position to address crucial questions related to neuroinflammation and epilepsy
in my own laboratory using cutting edge approaches, and will substantially impacting my research and career.
These aims will improve the knowledge of the relationship between inflammation and seizures, and has the
great potential of revealing inflammatory macrophages as a novel therapeutic target of neuroinflammation,
allowing for the development of novel intervention to prevent and treat the development of acquired epilepsy.

Public health relevance
Project Narrative Epilepsy (recurrent seizures) is a serious neurological disorder that can develop as consequence of viral infection and inflammation in brain. Expanding our understanding on the mechanism of how inflammation leads to seizures, will allow for the development of novel therapeutical treatments to prevent or even cure epilepsy.